The Genetic Architecture of Human Facial Morphology

PROJECT SUMMARY/ABSTRACT
Human facial morphology varies both within and among populations, and this variation is driven in large part by
genetic factors. Over the past seven years, gene mapping studies have identified numerous chromosomal
regions associated with normal-range facial variation. Using advanced methods of biological shape analysis,
our group recently uncovered over 200 such regions. Despite our success, these signals collectively explain
only a small fraction of the heritable variation in facial shape, suggesting that much of the genetic architecture
underlying human facial shape is yet to be discovered. A more complete understanding of this genetic
architecture may provide insights into the mechanisms that control how the human face forms, offer insights
into the etiology of craniofacial syndromes and birth defects, and eventually lead the way toward genetically-
informed personalized therapeutic interventions for craniofacial surgery and orthodontics. Critically, we also
lack knowledge about which genetic variants are functionally active at the implicated chromosomal regions or
which genes they even target, limiting our ability to design future studies to sort out the biological mechanisms
involved in building faces. The current proposal has three aims designed to significantly advance our
understanding of human facial genetics: (1) we will perform a series of high-throughput experiments designed
to delineate functional variants from our gene-mapping studies that drive craniofacial gene expression; (2) we
will leverage new sources of data to bolster the statistical power of our gene-mapping efforts, paving the way
for the discovery of new genetic pathways and a deeper understanding of the complex genetic networks and
interactions that underlie variation in facial features; and (3) by applying innovative image processing and
morphometric modeling techniques, we will utilize a large longitudinal dataset of over 11,000 adolescents with
genetic markers and craniofacial images available at multiple timepoints to scan the genome for variants that
impact key aspects of facial growth, such as timing of maturation and rate of change. Understanding the
genetic basis of these growth traits has potential clinical relevance for fields like craniofacial surgery and
orthodontics, where an individual’s facial growth trajectory can be an important factor in personalized treatment
planning. By connecting genotypes to facial phenotypes and subsequently delineating functional variants, this
project promises to fill gaps in our knowledge about the genetic basis of human facial traits and offer novel
insights into the molecular mechanisms underlying both normal and abnormal facial development.

Public health relevance
NARRATIVE The identification of genetic factors that influence the size and shape of typical human facial features can provide important insights into the biological mechanisms that contribute to both normal and atypical facial development. The current proposal seeks to expand our knowledgebase by leveraging existing datasets to map genomic regions associated with human facial morphology, delineate functional variants at implicated loci with high-throughput experimental screening tools, and identify variants across the genome that impact clinically-relevant aspects of facial growth.